Human evolution and the genetic architecture of complex traits

ABSTRACT
Our research aims to uncover the ways in which evolutionary forces shape patterns of genetic variation and drive
phenotypic variation across human populations. We focus on three broad areas of investigation. Firstly, we ex-
plore the effects of recessive deleterious alleles and associative overdominance (AOD). While previous studies
have mainly focused on additive fitness effects, we investigate the unique patterns of genetic variation caused
by recessive deleterious alleles. We analyze additional summary statistics such as the site frequency spectrum
(SFS), ancestral recombination graphs (ARGs), and haplotype structure to better understand the impact of AOD.
We also examine the dynamics of genetic diversity in the context of demographic changes and investigate the
likelihood of AOD in the MHC locus of the human genome. Secondly, we move beyond traditional racial and
ethnic categorizations and develop a more refined approach based on genetic relatedness groups. We utilize
ancestral recombination graphs (ARGs) to trace genetic lineages over time and identify relatedness clusters
without relying on predefined reference populations. Our analysis focuses on different timescales, including con-
tinental and sub-continental population structure, allowing us to capture the complexities and variabilities within
human populations. Lastly, we build simulation tools that incorporate genetic and non-genetic interactions to
study complex traits. By integrating statistical methods, population genetics theory, and flexible simulation tools,
we aim to simulate multivariate traits with varying genetic architectures. We focus on both common and rare
variants, developing power simulators for rare variant association tests (RVATs) to address the challenges of
studying rare variants in complex populations. Overall, our research aims to provide novel insights into the evo-
lutionary mechanisms driving phenotypic variation and enhance the realism and accuracy of simulations for
studying complex traits in diverse human populations.

Public health relevance
NARRATIVE Our research focuses on using evolutionary thinking and modeling to understand complex biological phenom- ena, with two fundamental questions that drive our work. How do evolutionary forces interact to shape the intri- cate patterns of genetic and phenotypic variation across the dynamic continuum of human populations? How can we harness the power of population genetics and computational modeling to unlock the hidden molecular mechanisms underlying complex traits, revolutionize our understanding of human health, and pave the way to- ward equitable precision medicine?